tRNA processing and nuclear-cytoplasmic dynamics

Project Summary
The equipment supplement funds will facilitate parent grant GM122448 (A.K. Hopper, PI) by supporting purchase
of an Integra Mini 96-channel pipetter which will greatly facilitate original proposed work in Aims 2 and 3.
GM122448 focuses on tRNA biology and its subcellular trafficking. tRNAs are small noncoding RNAs that are
essential for decoding the genome by delivering amino acids to translating ribosomes according to codon
directions in mRNAs. Defects in tRNA biology cause numerous human disorders from metabolic diseases, to
neuromuscular diseases, and to cancer. tRNA biology requires a complex set of conserved gene products for
post-transcriptional processing, subcellular traffic, and intron turnover. The research program impacts upon
multiple facets of gene expression, quality control, and issues important to human health. We employ budding
yeast and in vivo technologies to discover unknown important aspects of tRNA biology. In Aim2 of GM122884
we study trafficking of tRNAs between the nucleus and the cytoplasm. Although for decades it was thought that
tRNA movement is unidirectional, nucleus to cytoplasm, we co-discovered that tRNAs move bi-directionally
between the nucleus and the cytoplasm (Shaheen & Hopper 2005) and that the dynamics are conserved
between yeast and vertebrate cells (Shaheen et al. 2007). We developed a new methodology, the HCl/aniline
assay (Nostramo et al. 2020), that reports tRNA retrograde nuclear import and re-export to the cytoplasm. We
are employing this methodology in a genome-wide screen of ~6000 yeast genes to identify and characterize the
proteins functioning in the tRNA retrograde pathway. Aim 3 of GM122884 investigates tRNA introns. Possession
of tRNA introns in subsets of tRNA genes has been conserved from Archaea to humans. We recently made the
exciting discovery (Nostramo et al., Mol. Cell, in revision) that introns spliced from pre-tRNAs provide a novel
complementary-dependent mechanism to fine-tune basal mRNA levels and to assist cellular responses to stress.
We also learned that under particular stresses, subsets of tRNA introns accumulate to high levels due to
increased stability. We discovered one mechanism for tRNA intron turnover (Wu & Hopper 2014); however, there
are at least four additional unknown mechanisms to destroy tRNA introns. None of the yeast annotated RNases
appear to function in the unknown turnover pathways. Thus, we are conducting a genome-wide screen for
mutants that accumulate each of the 8 tRNA intron families whose turnover remains unknown. Although we are
able to grow yeast mutants in the deep 96-well plates, we are unable to extract RNAs in this format due to the
opaqueness of the microtiter plates; therefore, we must conduct the biochemical steps in labor-intensive
analyses of single mutants. The Integra Mini 96-channel pipettes will allow us to conduct all steps preceding
northern gel analyses for 96 strains simultaneously and thereby greatly reduce the time and safety to complete
Aims 2 and 3.

Public health relevance
Project Narrative tRNAs are essential for decoding the genome and regulating the proteome in response to nutrient availability and stress. We employ the powerful budding yeast model system and genetics/genomics, microscopy, molecular, and biochemical in vivo technologies to resolve key unknowns including tRNA nuclear/cytoplasmic bidirectional trafficking, quality control, and intron turnover/function. The requested Integra Mini 96-well channel pipette will facilitate genome-wide screens to discover importers/regulators of tRNA retrograde nuclear import and identify tRNA intron turnover machinery by allowing high throughput biochemical/molecular procedures to be conducted in the 96-well format.